Characterization of vsp/vlp system of Borrelia recurrentis

PROJECT SUMMARY
Louse-borne relapsing fever (LBRF) is a strictly human disease caused by louse-borne Borrelia recurrentis. To
date, LBRF has been a significant burden in several African nations. LBRF may account for up to 27% of hospital
admissions. The mortality can be as high as 40%, if left untreated, and low as 1-5% when treated with
antimicrobials. LBRF is characterized by fever relapses associated with spirochetemia, which are driven by the
antigenic variation system made of vsp and vlp (pseudogenes)genes, allowing spirochetes to evade antibodies.
To date, the vsp/vlp system of B. recurrentis remains uncharacterized (knowledge gap), which is in contrast to
the well-defined vsp/vlp system of Borrelia hermsii. LBRF research has been hampered by the lack of
immunocompetent animal model. Recently, by using the Collaborative Cross (CC) resource, we developed an
immunocompetent mouse model. For that, A17 strain was used and the infected mice consistently developed
an increasing level of spirochetemia during day 1-3 pi. However, the mice did not develop any detectable
spirochetemic relapse(s). Our recent unpublished data demonstrated that, unlike strain A11, B. recurrentis strain
A1 developed multiple relapses over a 20-day period in CC046 mice. By whole genome sequencing A1 via
PacBio, we were able to define the antigenic variation system of B. recurrentis A1. Based on the presence (or
absence) of promoter sequences, a total of 29 vsp/vls pseudogenes, 23 silent vsp/vlp genes, and 6 putative
active vsp/vlp genes were identified. The 6 putative active expression genes were separately located on different
linear plasmids (lp190, lp55, lp42, lp35, and lp23) and the chromosome, and were adjacent to telomeres. Given
that in B. hermsii, there is only a single vsp/vlp expression gene, which is located on a single plasmid and
adjacent to the telomere, it is hypothesized that one of the 6 putative active vsp/vlp genes identified in B.
recurrentis strain A1 is the vlp/vsp expression site. To test this hypothesis, the following Specific Aim will be
pursued:
Specific Aim: Deletion one of the six putative active vsp/vlp genes will disable the antigenic variation
system of B. recurrentis strain A1.
To test the hypothesis, we will produce 6 A1 vsp/vlp knockout mutants by deleting one of the six putative active
vsp/vlp genes in each knockout; and the respective six in cis complements. All mutants will then be tested in
CC046 mice for their capacity to establish spirochetemic relapses. The novelty of this application is multifold and
includes the use of novel mouse model and PacBio data, and proposed application of targeted deletion to
generate B. recurrentis mutants. The expected data will provide the insight into the vsp/vlp system of B.
recurrentis, the knowledge, which could ultimately be utilized for developing therapeutic measures against LBRF.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because this work will decipher the antigenic variation mechanism through which Borrelia recurrentis, the agent of louse-borne relapsing fever (LBRF) establishes bacteremic relapses in LBRF human patients. The antigenic variation system is critical for B. recurrentis to evade human antibodies. The anticipated results will advance the knowledge on this neglected disease and its pathogen.